DISTRICT OF COLUMBIA PARTNERSHIP FOR AIDS PROGRESS (DC PFAP)

The National Institutes of Health (NIH) Clinical Center, Critical Care Medicine Department (CCMD), manages a research program in the District of Columbia and at the Clinical Center, NIH entitled: District of Columbia Partnership for HIV/AIDS Progress (DC PFAP). This program is an intramural-extramural partnership which has the overall goal of performing research on how to reduce the number of new cases of HIV in the city, how to reduce the number of patients not successfully treated for HIV, and how to reduce the impact of HIV and its comorbidities on the population. The over-arching goal is to produce research that demonstrates a model that other urban areas can follow to reduce the burden of HIV/AIDS in their jurisdictions.